The role of Rok and its substrate Cmb the male germline

The role of Rok and its substrate Cmb the male germline
Traditionally, Rho kinase (ROCK, Rok in flies) functions as effector of the non-canonical
Wnt/Frizzled PCP pathway during gastrulation and neural tube formation. It also affects epithelial
barrier formation and is required for cell migration and metastases formation. Unsurprisingly, both
the up- and downregulation of Rok activity can cause severe developmental defects. However, a
function for Rok in the male germline has never been addressed.
Here, we have identified a novel function for Rok and its substrate Combover (Cmb) in the
male germline in Drosophila, where both are required for spermiogenesis and proper sperm
separation and packaging. Our proposal addresses the hypothesis that, downstream of Rok,
Combover orchestrates a novel transition checkpoint between axoneme elongation and sperm
individualization. In particular, our preliminary data suggest that Cmb coordinates the cytoskeleton
with the plasma membrane, thus ensuring proper growth and resolution of the syncytial
spermatids into functional sperm that are encapsulated by their own plasma membrane.
Our identification of Rok and Cmb as critical components necessary for male gametogenesis
will have wide-ranging implications for sperm development beyond Drosophila: syncytial
mammalian spermatids have to individualize during spermiation, a process that, although different
in detail in mammals, nevertheless, as in flies, requires tight encapsulation of the sperm tail with
its membrane while shedding unnecessary cytoplasm. The biomedical significance of sperm
individualization is further exemplified by the presence of multiciliate spermatozoa and spermatids
with unresorbed cytoplasm in infertile men.

Public health relevance
Project narrative The formation of functional sperm is key to reproduction and its failure leads to infertility in men. Key aspects of spermatogenesis is conserved and very similar between the fruitfly Drosophila and humans. We have identified a novel and unanticipated role of Rho kinase and its target Combover in spermatogenesis, the study of which is part of this application that thus will have wide implications for male fertility.